Harnessing mRNA Vaccine Technology for Precision Antimicrobial Delivery

ABSTRACT
The rise of antimicrobial resistance (AMR) presents an urgent global health crisis, projected to surpass
cancer as the second leading cause of death by 2050. Existing antibiotics are becoming increasingly
ineffective due to overuse, incomplete regimens, and insufficient pharmaceutical innovation. Endolysins are
bacteriophage-derived enzymes that effectively lyse bacterial cell walls, offering a targeted, alternative to
traditional antibiotics that do not readily elicit microbial resistance. Unlike broad-spectrum antibiotics,
endolysins have precise host specificities and can clear bacterial biofilms rapidly. However, their delivery
remains challenging. The use of an mRNA-based delivery systems offers significant advantages over direct
protein-based therapies, including cost-effective production, scalability, and sustained protein expression for
over a week. This innovative approach holds potential to revolutionize antimicrobial therapeutics by delivering
high-efficacy treatments at low cost, mitigating AMR, and opening new avenues for commercial and clinical
applications.
Our project seeks to establish a novel antimicrobial approach that combines endolysin proteins from
our metagenomic database with self-replicating mRNA (repRNA) delivery using lipid nanoparticles. This Phase
I proof-of-concept study focuses on two key objectives. First, we aim to evaluate whether repRNA can
successfully express a lysin which targets vancomycin-resistant Enterococcus faecium (VRE), a CDC-
identified high-priority pathogen. Second, we will assess whether this lysin produced in human cells via
repRNA maintains bacteriolytic activity.
Our proprietary library of over two million phage-host genome connections uniquely positions us to
select potent lysin candidates for further clinical development. By demonstrating the feasibility of mRNA-based
lysin delivery, this project lays the groundwork for rapid commercialization and broad clinical adoption,
addressing an urgent medical need. Success will accelerate the development of next-generation
antimicrobials, ensuring a more sustainable and cost-effective response to AMR.

Public health relevance
NARRATIVE Antimicrobial resistance (AMR) is on the rise and could make once-treatable infections life-threatening in the coming decades, with harmful impacts on global health. This project seeks to demonstrate proof-of- concept for a new type of antimicrobial therapy that combines precision enzymes which kill bacteria directly, and cutting-edge mRNA technology to deliver these enzymes. This has the potential to be more cost-effective and targeted than other approaches, and could protect future generations from resistant infections, improve public health outcomes, and save countless lives.